NEUROBIOLOGY OF PRIMATE SOCIAL BEHAVIOR

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The major goal of this program is to use lesion and behavioral techniques as well as noninvasive imaging in order to analyze the neural substrates of primate social behavior.